U-RISE at NMSU

PROJECT ABSTRACT
Diversity in the United States is no longer a future consideration; it is the reality of the current societal
landscape. In stark contrast to the population’s changing demographics, the population of leaders in the
biomedical enterprises of academia, government, and industry is relatively homogeneous. One way to
remedy this is for science communities to be intentional and specific in how equitable, inclusive, and diverse
scientific environments are fostered to welcome and support different perspectives. Current practice of
science creates the “diversity-innovation paradox.” Research demonstrating that rigorous, impactful science
and improved innovation result from diverse and inclusive workspaces, yet creative thinkers from Historically
Excluded Communities (HECs) are too easily excluded and their contributions valued less highly. Not
currently available to undergraduate students and their faculty mentors at NMSU is a program that blends
training in critical thinking laboratory skills, support in a multitude of relevant professional proficiencies, and
intentional community building among scholars from diverse cultural and academic backgrounds with
scientifically trained faculty mentors and staff. A two-year research education program is bolstered by an
inclusive and affirming educational seminar series built into students’ curriculum. Complementary activities
focus on knowledge, skills, and confidence in four major areas: basic research skills, quantitative-based
approach to analyze and solve problems, scientific communication skills and development of a science
identity. This application requests funds to train forty-five undergraduate scholars over five years. NMSU
can achieve this goal because of the institution's unique status as a doctoral, research-intensive, land grant,
minority (Hispanic) serving university with a diverse student population, a cadre of accomplished mentors, a
growing collaboration among different university units focusing on postbaccalaureate education of NMSU
students, and a strong institutional record of successfully increasing the diversity of trainees in the biomedical
sciences nationwide. This application introduces innovative elements that are evidence-based interventions
that 1) strengthen the students’ understanding of the ethical norms in scientific research by applying critical
thinking skills and a quantitative-based approach to analyze and solve problems (Aim 1); 2) Implement a
curriculum that addresses development training skills in management, inter-personal communication,
presentation, and promotes faculty-student relationships to be grounded in open communication, support
and allyship – all practices which foster a scholar’s science identity (Aim 2); and 3) Cultivate the interface
between biomedical, social, environmental, and agricultural scientific fields that relate directly to human
health and well-being by increasing the inclusion of students from other colleges into biomedical research
experiences like the levels observed in the college of Arts and Sciences (Aim 3).

Public health relevance
PROJECT NARRATIVE The NMSU U-RISE will contribute to broadening participation and retention of undergraduate students from Historically Excluded Communities (HECs) in research areas of interest to the National Institutes of Health. To accomplish this goal, NMSU has assembled a two-year research education program for Junior- level students comprised of a) a thoroughly immersive research program, b) an inclusive and affirming educational seminar series built into students’ curriculum, c) a mentorship education that promotes faculty- student relationships to be grounded in open communication, support and allyship, and d) expansion of research experiences to NMSU students in the agricultural sciences and social-public health fields at NMSU. This program seeks to strengthen inclusive, equitable, and diverse scientific environments at NMSU that will welcome different perspectives, spark the most innovative ideas, and improve our research education programs for current and future scientists from HECs.